Socioecological Study of Autism, Suicide Risk, and Mental Health Care: Multilevel Analyses and Community Consultation for Suicide Prevention

Autistic people are at increased risk of suicide behaviors (SB), including suicidal ideation and suicide attempts,
and have higher rates of suicide death compared to non-autistic people (use of ‘autistic’ reflects community
language preferences). Yet there is limited understanding of the mutable factors related to risk of SB for the
autistic population. Beyond biological and behavioral traits, research with the general public reveals multiple
social determinants of health (e.g., community-level resources, health policies) contribute to risk of SB.
However, the impact of individual, community, and policy factors on risk of SB in the autistic population is
unknown. Meaningful improvements in policy and practice will require an understanding of (1) how risk of SB
clusters for autistic individuals across interdependent individual, community, and policy factors and (2) the
current state of mental health service (MHS) provision among autistic people.
To contribute to the long-term goal of reducing risk of SB for the autistic population, this project uses a
sequential, mixed methods design, in collaboration with an established team of autistic stakeholders and policy
and practice experts, to analyze multilevel, socioecological factors associated with risk of SB and receipt of
MHS and to generate community-supported recommendations for suicide prevention. Aim 1 will identify
clusters of socioecological factors (at individual, community, and policy levels) associated with risk of SB
among two national samples of autistic youth and adults. Autistic people (aged 12-64) will be identified in two
national healthcare claims databases (MarketScan private, CMS Medicaid) and integrated with public use and
proprietary databases to create multilevel, longitudinal datasets containing individual, community, and policy
factors. Data reduction, hierarchical clustering, and multilevel analytic techniques will partition individuals into
homogeneous groups based on shared characteristics to identify underlying factors associated with risk of SB
among autistic people. Next, using the databases developed in Aim 1, Aim 2 will evaluate socioecological
factors associated with MHS receipt (psychotherapy, pharmacology, both, neither), dose (visits/year), and
delivery modality (face-to-face, telemental health, both) for autistic people with documented SB and/or co-
occurring mental health conditions. Informed by critical findings from Aims 1 and 2, through collaboration with
autistic stakeholders and focus groups with additional autistic adults, family caregivers, and MHS clinicians,
Aim 3 will establish community-supported recommendations to reduce risk of SB and facilitate receipt of MHS.
In response to RFA PAR-23-095 and aligned with the NIMH strategic plan, this project will optimize real-world
data collection systems to characterize clusters of multilevel risk factors of SB and factors associated with
receipt of MHS among autistic people. Study results will produce translatable, community-informed evidence
and recommendations aimed at reducing risk of SB and improving MHS delivery for autistic people.

Public health relevance
Autistic people have significantly heightened risk of suicide deaths and suicide behavior (SB), yet there is limited understanding of mutable factors related to risk of SB for the autistic population. There is a significant need to understand how interdependent individual, community, and policy factors influence risk of SB and mental health service receipt to contribute to the long-term goal of reducing risk of SB for the autistic population. In collaboration with an established team of autistic stakeholders and policy and practice experts, this project will identify and characterize multilevel, socioecological factors associated with risk of SB and receipt of mental health services among autistic people, and generate evidence-based, community-supported recommendations for suicide prevention.